Development of Sulfur-Based Reactions with Translational Applications

Abstract
Synthesis and coupling of hindered and strained functional molecules and bioisosteres represent
underdeveloped yet synthetically powerful transformations. This research project is focused on the discovery of
both stoichiometric and catalytic sulfur mediated couplings, which might that potentially overcome several
limitations often encountered in traditional transition-metal couplings. Our research heavily relies on UPLC
analysis and purification because of the reaction development, molecular complexity and unique physical
properties of sulfurane, boronates, bicyclo[1.1.1]pentanes, sp3-rich amines and other polar bioactive molecules.
The goal of this administrative supplement application is to strengthen the analytical capability of this research
program.

Public health relevance
Narrative Not applicable.